Research training in drug abuse prevention: closing the research-practice gap

Abstract
Despite clear and convincing evidence for the efficacy of preventive interventions in preventing substance use
and abuse (SU/A), the public health impact of these programs has been limited by inadequate uptake in
community settings. This application seeks to train 3 pre-doctoral and 3 post-doctoral fellows annually to
conduct research that reduces the gap between real-world practice and evidence-based preventive
interventions targeting SU/A. The proposed background is a renewal of our current NIDA-funded T32 (currently
in Year 5) and builds on a lengthy and successful 33-year history of T32 training that has been funded by
NIMH from 1987-2014 and NIDA from 2014-present. Our training program is informed by the translational
research cycle and Chambers and Proctor's recommendations on training for early career Dissemination &
Implementation (D&I) researchers. The training is housed at ASU's REACH Institute, and participating units
include the Arizona State University (ASU) Department of Psychology and School for Social and Family
Dynamics. The interdisciplinary training faculty will be drawn from these units, as well as existing collaborators
from College of Health Solutions, W.P. Carey Colleges of Business, Edson College of Nursing and Health
Innovation, Fulton Schools of Engineering, Hugh Downs School of Human Communications, School of
Criminology and Social Justice, and the School of Social Work. Training faculty conduct numerous NIH-funded
projects in which collaborative research teams design, implement, and evaluate theory-based preventive
interventions in natural service delivery settings and study the implementation science questions related to
successful program uptake. Training faculty have unique strengths in SU/A prevention, D&I, culture and health
disparities, and research methodology (particularly quantitative methods). The program is guided by an
External Training Faculty of national experts in implementation science and a Community Advisory Board
composed of decision leaders from service delivery settings (schools, courts, health care, and mental health
care settings), with whom we partner on community-based research projects. Training consists of mentored
research apprenticeships, an ongoing training seminar (including training in ethics and career development),
required courses in SU/A and D&I, and other relevant experiences based on Individualized Training Plans that
will be co-created with mentors. Through this tailored combination of coursework and research
apprenticeships, trainees acquire skills in designing interventions for implementation, models of cultural
adaptation, technology-based interventions, community-based participatory research, implementation theory
and design, organizational characteristics, and economic analysis. The research contributions of our trainees
will increase the adoption of evidence-based interventions in real world practice, helping to realize their public
health impact at the population level.

Public health relevance
Project Narrative Despite clear and convincing evidence for the efficacy of preventive interventions in preventing substance use and abuse (SU/A), the public health impact of these programs has been limited by inadequate uptake in community settings. We respond to this public health need by training pre-doctoral and post-doctoral researchers in the implementation science agenda that is needed to reduce the research-practice gap in SU/A prevention.